Examine the local glucose dynamics in activity-induced hippocampal neurogenesis

Abstract
The overall goal of this proposal is to explore the local cellular glucose dynamics in regulating activity-
induced hippocampal neurogenesis. Hippocampal neurogenesis sensitively responds to physiological,
behavioral, and unfortunately also pathological stimuli. It has been and is continuously being an essential
question: how brain activities, no matter they are physiological or pathological stimuli, regulate the generation
and circuit integration of new hippocampal neurons in the adult brain. In this explorative proposal, how adult
brain actively regulates the local glucose dynamics in response to brain stimuli and eventually regulates
neurogenesis will be studied. Two sets of experiments have been proposed. 1) Examine the local glucose
dynamics during the hippocampus-engaged behaviors. The glucose dynamics in the astroglia of the dentate
gyrus during the contextual exploration will be determined. The level of glucose in astroglia will be measured
in real time manner during the regular and enhanced exploration behavior. The intercellular transportation
machinery of glucose-derived metabolite, lactate, in the dentate gyrus will be examined. 2) Determine the role
of local glucose dynamics in regulating activity-induced hippocampal neurogenesis. The potential effect of
glucose dynamics in the dentate gyrus on the survival of new hippocampal neurons will be tested. The glucose
transporters of astroglial cells or neural progenitors will be knocked down and the survival of newly generated
neurons will be tested. The findings will ultimately provide insights into the understanding of how the cellular
glucose dynamics change in response to hippocampus-engaged behaviors and how the glucose dynamics
account for the activity-induced hippocampal neurogenesis.

Public health relevance
Disease, degeneration, or traumatic injury of the nervous system are among the greatest public health concerns in the United States and are generally considered irreparable, often causing catastrophic damage to the functional capacity of the individual. Now, however, characterization of neural stem cells residing within specific germinal centers of the brain and in cell culture raises hope that functional regeneration of nervous tissue may be feasible, if we learn to exploit adult neurogenesis for clinical benefit. The research proposal here aims to study how adult brain reacts and responds to our daily lives to adjust its hippocampal neurogenesis through local glucose dynamics, expecting an improved understanding of neural stem cell biology, possibly leading to the development of new drugs for repair and regeneration of the nervous system such as injured brains.